Arrays of bottomless picowells for the analysis of biological age using high-resolution imaging

Abstract
Identification and validation of biomarkers of aging, which predict the lifespan and risk of disease better than
chronological age and can help identify factors that accelerate aging and interventions that promote resilience,
is the major goal of the Predictive Biomarkers Initiative of the NIA. DNA methylation (DNAm) clocks, which
provide assessments of chronological and biological age, have attracted a lot of attention and have been
incorporated into multiple commercial products. Nevertheless, the DNAm clocks are usually based on
averages over large pools of cells of different types and extract age-related trends from noisy data. Recently,
the Co-PI lab pioneered the analysis of cellular states, identities, and perturbations based on high-resolution
confocal imaging of epigenetic marks in nuclei of individual immuno-labeled cells and applied this approach to
aging. The imaging-based chromatin and epigenetic age (ImAge) analysis captures the principal changes in
the spatial organization of chromatin and epigenetic marks that correlate with biological age. The cell-to-cell
variability of the ImAge readouts increases with age, making it a separate metric of the process of aging and
highlighting the value of obtaining the quantitative epigenetic signatures from single cells. ImAge
measurements require only small amounts of Peripheral Blood Mononuclear Cells (PBMCs) that can
potentially be obtained from fingerstick blood samples. To effectively implement ImAge for assessing the
human biological age, PBMCs obtained from a fingerstick must be immuno-labeled and presented for high-
resolution imaging with minimal cell loss. To meet this challenge, we propose a platform for single-cell capture,
immuno-labeling, and high-resolution imaging of PBMCs in arrays of bottomless microscopic conical wells with
picoliter volumes. When captured in a conical picowell, a round cell rests on the tilted sidewalls and remains
motionless under moderate mechanical perturbations, including medium exchanges during the immuno-
labeling. The major advantage of the proposed bottomless conical picowells is that the cell loading is by
vertical flow through the picowells, thus minimizing the cell loss, increasing the proportion of picowells with
single cells, and filtering out cell debris. We will develop and validate an ImAge platform based on arrays of
bottomless picowells and fluidic perfusion devices. We will apply it to obtain the first ImAge dataset of human
PBMCs from healthy donors of different ages. When fully developed and tested, the proposed bottomless
picowell-based platform will enable cost-effective longitudinal tracking of biological age of individual patients to
facilitate personalized medicine and to achieve a better understanding of how aging is affected by different life
events, environmental changes, and medical interventions.

Public health relevance
Narrative We propose the development and validation of a novel technology of arrays of bottomless conical picowells for efficient capture and high resolution imaging of peripheral blood mononuclear cells (PBMCs). The bottomless picowell arrays will be incorporated into fluidic devices and used to assess the biological age of blood donors by quantifying the biomarkers of age in single immuno-labeled PBMCs. The proposed technology will enable the testing and longitudinal tracking of biological age of individual patients with PBMCs obtained from small blood samples collected with fingerstick.